Hummink NAZCA High-Precision Capillary Flow Printer

ABSTRACT
Controlled deposition of materials is central to realizing a wide variety of biomedically relevant devices, from
immunoassays to microfluidics. Well-established printing techniques such as inkjet and aerosol jet have opened
new possibilities for scaling down material consumption while boosting performance of devices; however, these
printers are limited to resolutions > 10 microns with restrictions on printable ink properties that often preclude
utility in many biomolecule printing applications. The Hummink NAZCA printer is a first-of-its-kind capillary flow
printer that offers < 1 µm resolution and compatibility with inks spanning a broad range of viscosities. Operation
of the printer is simple: A small volume of ink is loaded into a glass micropipette, which is brought into close
proximity with a substrate such that deposition proceeds via capillary forces. The system borrows its core
operation control from atomic force microscopy (AFM), making it possible to offer dual functionality as a
deposition and imaging tool. Over the last six months, Duke University has been the first institution in the United
States to test the NAZCA via a rental agreement with Hummink and already the impact on numerous NIH-funded
projects has been significant. We have realized the first fully printed submicron electronic biosensing transistors,
demonstrated enhanced biomarker detection with printed nanoparticles for surface-enhanced Raman
spectroscopy, and shown an order of magnitude reduction in costly biomolecular (e.g., antibody) ink usage for
immunoassay printing. Hence, our team of 4 Major and 5 Minor Users seeks this S10 Shared Instrumentation
Grant to support the acquisition of the NAZCA to continue supporting the already impacted projects and enable
numerous other NIH-relevant work. Seven NIH-funded R01 projects will immediately be impacted by the
advantages the NAZCA tool provides for high-resolution printing. Long-term objectives for the NAZCA are to
provide a novel, shared-use instrument for low-volume, direct deposition of materials and to facilitate new
research directions in spaces such as DNA origami, biomedical wearable sensors, and nanofiber formation for
nerve defect repair.

Public health relevance
PROJECT NARRATIVE Advances in biomedical devices depend on the controlled deposition of materials, including electronic and biomolecular materials. The Hummink NAZCA is a novel materials printing system capable of forming features down to sub-micrometer resolution from a vast array of inks using capillary flow printing. This project seeks to acquire a NAZCA for shared use at Duke University to facilitate high-resolution printing of immediate and long- term impact on NIH-funded projects ranging from point-of-care biosensors to nerve defect repair.